Core B: Developmental

PROJECT SUMMARY/ABSTRACT
The goal of the Developmental (Dev) Core (Core B) of the Emory CFAR is to develop the next generation of
outstanding HIV investigators with an emphasis on women and underrepresented minority (URM)
investigators. The Dev Core takes an innovative, holistic approach to investigator development that builds on
an integrated set of services, support, opportunities, and referrals that are designed to assist early-stage
investigators (ESIs) and established scientists new to HIV research to obtain funding and connect with CFAR
mentors and collaborators, services, and resources. Core users will be supported and encouraged to use any
of the Dev services that will help advance their science and their career in HIV research. Dev Core users will
also be introduced to the full range of CFAR Science Core services, encouraged to participate in the CFAR
Scientific Working Groups as appropriate, and informed of all CFAR-hosted programs and seminars, including
the monthly Emory CFAR Network Science Seminar series.
In the next project period, the Dev Core will continue to build on successful programs and add new initiatives
that extend the Core's reach and fill identified gaps in service, such as systematic pre-submission review and
research idea design thinking. Dev Core activities will emphasize team science, innovative methods for
community engagement in study development, and effective partnerships with Emory-wide grant development
offerings to encourage collaboration and to increase impact. The Core will employ regular evaluation of its
activities to inform the extent to which services meet the needs of mentees and to provide opportunities for
process improvement throughout the award period.
The Emory CFAR Developmental Core will accomplish its goals through the following specific aims:
Aim 1. Offer research funding opportunities to promote individual and team science, to elevate community
engagement, and to expand the ethnic and racial diversity of funded HIV researchers.
Aim 2. Implement proposal development activities to increase the competitiveness of HIV research
applications submitted to the NIH.
Aim 3. Provide mentoring for early-stage investigators, as they transition from trainee to independent
investigator, through structured research resources and support.
Aim 4. Support professional development activities to assist CFAR Members in cultivating new or enhanced
expertise in research and multiple modes of science communication.